Targeting sfRon-S6K1 signaling and mitotic kinesin Eg5 in ovarian cancer: a novel synergistic treatment strategy

PROJECT SUMMARY
Ovarian cancer remains the deadliest of all gynecologic malignancies nationwide. Unfortunately, current ovarian
cancer treatment leads to chemoresistance and a rapid tumor recurrence in more than 85% of patients. The
project outlined here represents a much needed new opportunity for therapeutic intervention. Our previous
published and ongoing work, has revealed that short-form Ron (sfRon), a truncated isoform of the full-length Ron
(flRon) receptor tyrosine kinase, can drive ovarian cancer development and progression. Previously, we showed
that sfRon preferentially signals through the PI3K pathway, and that the key sfRon effector S6K1 is crucial for
tumor promoting effects. Our preliminary findings revealed a novel function of sfRon-S6K1 signaling in inducing
mitotic progression of the cell cycle. These data led to drug screening studies showing that the inhibition of sfRon
or S6K1 (by BMS777608 or AD80, respectively) renders ovarian cancer cells particularly vulnerable to mitotic
kinesin Eg5 inhibitor Ispinesib. We hypothesize that a synergistic combination therapy simultaneously
blocking sfRon or S6K1 and mitotic kinesins could prove an effective precision treatment for advanced
ovarian cancer. To test this hypothesis, we propose two specific aims: (1) We will determine the mechanism by
which sfRon promotes the mitotic progression of cell cycle. We will test if depletion of sfRon and/or S6K1
signaling by genetic and pharmacological approaches affects cell proliferation, cell cycle distribution, and mitotic
progression or proper function of critical mitotic regulators such as Aurora B and/or Plk1. Further, we hypothesize
that the depletion of S6K1 contributes to mitotic slippage of ovarian cancer cells sensitizing them to Ispinesib.
To test that, we will compare the effects of sfRon, S6K1, and mitotic kinesin inhibitors as monotherapy or in
combination and determine the drug-induced cell fate including mitotic arrest, mitotic slippage, and cell death.
(2) We will determine if synergistic combination therapy blocking sfRon-S6K1 signaling and mitotic kinesins leads
to a potent and sustained antitumor efficacy using clinically relevant patient-derived xenografts (PDXs). We will
use chemotherapy naïve PDXs and determine if the inhibition of sfRon synergistic pathways results in a more
sustained anti-tumor response than standard chemotherapy. In recurrent disease setting, we will use our
chemoresistant PDX models and investigate if the combination therapy is an effective treatment regimen for
recurrent ovarian tumors that currently have very limited treatment options. This proposal will expand our
understanding of the mechanism by which sfRon and/or S6K1 regulates the mitotic progression of cell cycle. It
will also provide new insight into why sfRon-S6K1 inhibition renders ovarian cancer cells particularly vulnerable
to mitotic kinesin inhibitors. In the long-term, this project could offer a new precision therapy designed to achieve
a clinically meaningful and sustained anti-tumor response to even chemoresistant ovarian tumors.

Public health relevance
PROJECT NARRATIVE Our studies revealed a novel function of sfRon-S6K1 signaling in inducing mitotic progression of the cell cycle. These findings led to drug screening studies that revealed a potent synergistic combination therapy simultaneously blocking sfRon or S6K1 and mitotic kinesins, which could prove an effective precision treatment for ovarian cancer. Our work focusing on previously unknown mechanisms of sfRon-mediated cell cycle regulation in ovarian cancer and voulnerability to selected drug combinations will provide valuable information to the general scientific community, and will impact a broad spectrum of researchers studying different tumor types.